Task 01: Screening of Compounds for Category A, B and C Pathogens

The In Vitro and Animal Models for Emerging Diseases and Biodefense contract provides antimicrobial activity testing capabilities. This contract also provides the development and standardization of small animal and non-human primate models, and may include efficacy testing of therapeutics; therapeutics that are efficacious in small animals may be further tested in non-human primate models. This task focuses on the screening of compounds against a wide variety of Category A-C pathogens.